RESTRICTION FRAGMENT LENGTH POLYMORPHISMS IN NORMAL AND NEOPLASTIC TISSUES

The major goal of the research effort is to define genes involved in the pathogenesis of urologic malignancies. Our major accomplishment this year is the isolation of the von Hippel-Lindau disease (VHL) tumor suppressor gene. The newly isolated gene appears to play a major role in the pathogenesis of sporadic renal cell carcinoma.